Leadership, Planning, and Evaluation

LEADERSHIP, PLANNING, AND EVALUATION: ABSTRACT
The University of Arizona Cancer Center (UACC) aspires to serve as the trusted source and greatest hope for
cancer patients and caregivers. This will be accomplished through high-impact collaborative research and
transdisciplinary translational discoveries that help reduce cancer risk and enhance outcomes. UACC’s vision
is to be a national leader for overcoming cancer risks, improving treatments, training talented scientists and
providers, and engaging communities though a shared determination to discover, innovate, and remove social
inequities. This vision is realized through the mission, which is to alleviate the burden of cancer on patients and
families within UACC’s five-county Catchment Area and beyond through: (1) a quest for scientific discovery
through interdisciplinary collaboration and team science; (2) increasing access to cutting-edge approaches to
care during a patient’s cancer journey; (3) preparing generations of researchers and health professionals to
fight each day against cancer and the inequities affecting vulnerable populations; and (4) providing national
leadership in engaging populations with respect, consistency, and shared conviction. In June 2020, Joann
Sweasy, PhD, was appointed as the Center’s first female Director. Over the project period, four new Associate
Directors and three Interim Associate Directors were appointed to the Center’s senior leadership team. Upon
becoming Director, Sweasy launched a highly engaged strategic planning process and developed the 2020–
2025 Strategic Plan, entitled Bear Down on Cancer, which will guide the Center for the next 5 years. The
UACC Executive Council, comprised of the Director and Associate Directors, is responsible for the
implementation and continuous evaluation of the Strategic Plan. Planning and Evaluation is further supported
at the institutional level by its senior leaders, Deans of Colleges, and Institute Directors, along with the UACC’s
Academic Medical Partner, Banner Health – Tucson. Progress toward meeting the Center’s strategic goals is
also evaluated by the Center’s External Advisory Board and Community Advisory Board as well as by ad hoc
experts. Additional internal advisory committees that support Planning and Evaluation activities include the
Executive Leadership Council, Scientific Leadership Council, Shared Resource Oversight Committee, Clinical
Research Oversight Council, and Internal Advisory Councils of UACC’s Community Outreach and Engagement
and Cancer Research Training & Education Coordination.